Core A-Administrative and Tissue Distribution

Core A Abstract
The main functions of the Administrative Core are to: a) facilitate distribution of research materials
and resources to the various investigators; b) facilitate communication between investigators,
cores the advisory committees, affiliated institutions and the funding agency; c) evaluate the
quality of ongoing research as well as programs to be considered for future expansion; d) cut
brain tissue specimens and harvest frozen specimens for distribution, in a blinded fashion for
investigators; d) interact with Core B and e) maintain a web page for the PPG. Core A functions
will be accomplished with the help of three different committees: 1) the Internal Advisory group
consisting of project and core leaders. It will meet on a monthly basis to discuss
research projects, protocols, results and any problems that might arise in this collaborative effort.
The External Advisory Committee which consists of scientists with expertise in various disciplines
represented in this application will meet with Internal Advisory Committee every other a year. In
the off years will employ video conferencing. The committee reviews progress and advises on the
overall quality of the PPG. Dr. Mufson chairs these meetings, which provide a forum for discussing
new ideas and a mechanism for expanding the program with high quality projects in the future.
The Administrative Core continues to be led by the Program PI, Dr. Mufson, and its Co-PL Dr.
Perez.